Launching Future Leaders in Global Health (LAUNCH) Research Training Program - Supplement for OAR

Contact PD/PI: Fawzi, Wafaie W
The HBNU Fogarty Global Health Training Program (the HBNU Program) fosters the next generation of
global health scientists and enhance research capacity in low- and middle-income countries (LMICs) through a
rigorous mentored research training plan for trainees early in their career. Specifically, it aims to support
trainee research focused on reducing the mortality and morbidity associated with: HIV/AIDS and associated
co-infections; noncommunicable diseases (NCDs) including cardiovascular disease, diabetes, and cancer;
mental health; and maternal and child health and nutrition (MCHN). In addition to mentored research, training
will include didactic components to develop competency in rigorous research design and methods, evaluation
and analytic capacity, regulatory issues, and cross-cultural collaboration.
The Program brings together leading academic research institutions with longstanding relationships in
LMICs in a variety of disciplines and with multidisciplinary research capacities. The inclusion of institutions that
have shown a historical commitment to educating students from groups underrepresented in biomedical
research is prioritized. The four U.S. academic research institutions that will anchor our consortium are:
Harvard University (Harvard T. H. Chan School of Public Health); Boston University (School of Public Health);
Northwestern University (Institute for Global Health, Feinberg School of Medicine); and the University of New
Mexico (School of Medicine, Center for Global Health).
Our consortium’s partner LMIC research sites are 18 well-qualified institutions in 14 LMICs. These sites
have strong pre-existing relationships with the Program’s principal investigators and institutions and have
demonstrated capacity to provide outstanding mentored experiences. Specific Aims include:
AIM 1: Recruit a diverse pool of qualified U.S. predoctoral and U.S. and LMICS postdoctoral applicants;
including at least 17 trainees per year for Years 1-2 and 16 trainees per year for Years 3-5, for a minimum of
82 trainees over the award period; AIM 2: Deliver a comprehensive education and research support program,
including Field Preparedness Training, Monthly Seminars, and U.S. based training for LMIC trainees, that will
combine in-person and online learning and access to collaboration tools to support trainee individual
professional development and research project implementation; AIM 3: Provide trainees with rigorous
mentored research experiences at LMIC research sites with a very strong track record of peer-reviewed
publications and NIH research outputs; AIM 4: Build LMIC and global health research capacity at consortium
member institutions and internationally through activities such as alumni mentors and the Mentor Symposium.
Ultimately, the Program will prepare a future generation of leaders to tackle and solve the most
challenging global health problems through early investment in committed predoctoral and postdoctoral
trainees to foster scientific creativity at a transformative stage in their career.
Project Summary/Abstract Page 7

Public health relevance
Contact PD/PI: Fawzi, Wafaie W Project Narrative The HBNU Fogarty Global Health Training Program, a consortium of Harvard University, Boston University, Northwestern University and the University of New Mexico, proposes to continue to contribute to global health research capacity building and the use of research to improve the health outcomes related to priority health areas in low- and middle-income countries (LMICs) in partnership with 18 sites throughout Africa, Asia, and South America. The Program will recruit US and LMIC trainees to strengthen global health research networks and programs at academic institutions and ultimately help sustain global health research in the US and LMICs. Project Narrative Page 8